Preclinical Testing of PI3K Inhibitors for Vestibular Schwannomas

ABSTRACT
Mutations in the merlin (NF2) tumor suppressor gene cause the benign tumor disorder, Neurofibromatosis type
2 (NF2). This disorder predisposes individuals to develop bilateral vestibular schwannomas (VS) that cause
progressive hearing loss and can cause life-threatening brainstem compression. Because surgical removal of a
VS often causes deafness, facial paralysis, and imbalance, there is a need to develop drug therapies to slow or
prevent VS growth and preserve nerve function. We have worked to establish an in vitro and in vivo drug
screening platform to identify novel compounds as well as FDA-approved drugs that can be
developed/repurposed for VS therapies. Toward this goal, we have created mouse and human merlin-deficient
Schwann cell lines and optimized their use in 384-well high-throughput and high-content assays in order to
screen large compound/drug libraries using robotic platforms. This approach identified several phosphoinositide-
3 kinase (PI3K) inhibitors that selectively reduce viability of mouse merlin-deficient compared to wild-type
Schwann cells with nanomolar IG50. This initial finding was confirmed in human merlin-deficient Schwann cell
lines for multiple PI3K, dual PI3K/mTOR and PI3K/HDAC inhibitors. Because PI3K plays a critical role in cell
proliferation, survival, and invasion, there are currently 15 different PI3K inhibitors in clinical trials for various
blood cancers and solid tumors. The first in class PI3K inhibitor (idelalisib) was approved in 2014 for leukemia.
In this proposal, we advance our findings by conducting a systematic screen of PI3K pathway inhibitors in vitro
and in vivo. The aims of this proposal are to: 1) profile a library of PI3K pathway inhibitors for efficacy in reducing
viability of human merlin-deficient Schwann cell lines and primary human VS cells; 2) test efficacy of the
advanced PI3K inhibitors to slow graft expansion and preserve hearing and balance in a novel rat xenograft
model, and 3) conduct phenotypic, kinome, and transcriptome analysis to reveal the molecular signatures and
adaptive changes of the cells and grafts to the inhibitors. We expect to obtain the necessary pre-clinical data to
support the potential use of PI3K inhibitors in patients with NF2-associated VS.

Public health relevance
Individuals with Neurofibromatosis Type 2 risk loss of hearing and balance due to growth of vestibular schwannomas on cranial nerve eight. In an effort to develop drug treatments for this condition, we will screen a library of phosphoinositide-3 kinase inhibitors against human Schwann cell lines and patient schwannoma cells. Promising inhibitors will be tested in a novel rat model in which graft growth, and hearing and balance will be measured. The outcome of the study is expected to be identification of a drug for future clinical testing in individuals with NF2-associated vestibular schwannomas.